Central and Peripheral Neuromodulation during Activity to Synergistically Augment Stroke Recovery

Stroke is a common disorder amongst veterans, with >15,000 veterans hospitalized each year for stroke, 85%
of which are ischemic strokes, and the incidence is significantly exacerbated in elderly patients and those with
PTSD. Even with early treatment of ischemic stroke with reperfusion most aged patients experience significant
residual deficits. Potentially synergistic phases of stroke recovery include early prevention of progression and
later recovery enhancement. Neural recovery can include enhanced axonal collaterals from both ipsilesional
and contralesional cortex to regain control of extremity function, which may be enhanced by neuromodulation
approaches of the central and peripheral nerve system. Vascular recovery includes initial latent collateral
opening as well as new vessel formation after ischemia, as measured with either laser speckle imaging [LSI] or
indocyanine green [ICG] cerebral blood flow imaging [CBF]. A basic principle of stroke rehabilitation is that
neural and vascular recovery require co-activation of neuromodulation together with intent to use the extremity.
However, after stroke, both exercise and activity are limited by severe functional deficits, which may be
potentially overcome with peripheral stimulation as a surrogate for intent to move. Co-activation with multiple
neuromodulation modalities applied during behavior (ie, sensory and motor activation) may further enhance
recovery based on both neuronal and vascular mechanisms.
Stroke recovery may be augmented through a wide range of neuromodulation techniques, including central
stimulation through transcranial approaches (ie, transcranial alternating current [tACS] or magnetic stimulation
[TMS]), vagal nerve stimulation, and sensory stimulation (of the wrist and hand), as well as high intensity
exercise. We have recently shown that tACS can enhance CBF in a rapid, dose-dependent manner and a
common mechanism underlying these central and peripheral neuromodulation techniques may be heightened
CBF around the stroke region together with neuronal activation. We propose concurrent neuromodulation
with tACS and peripheral activation together with active behavior to enhance mouse stroke recovery.
Our treatment hypothesis is that combined neuromodulation at both central and peripheral sites
during intentional activity will augment stroke recovery in aged mice through enhanced neural
plasticity and collateral blood flow. To address this hypothesis we will combine daily, focused tACS around
a photothrombotic stroke in motor cortex in aged male and female mice (18 months) together with peripheral
neuromodulation (sensory input via electrical stimulation) during activity and exercise, beginning at 3 days after
stroke induction for 4 weeks. We will compare animal groups with each neuromodulation approach and activity
alone to the synergistic combination by analyzing at 4 weeks: 1) dose-response curves of integrated EMG in
the forelimb contralateral to the stroke region to assess neural plasticity; 2) cortical LSI and fluorescent ICG
angiograms to evaluate CBF for vascular ingrowth, collateral formation, and hemodynamic responses to
sensory stimulation in the stroke region over time; 3) cognitive performance on the novel object recognition
task; and 4) motor performance of the contralateral forelimb. These translational experiments will provide a
novel approach to stroke rehabilitation through a clinically feasible protocol.

Public health relevance
Stroke is a common disorder amongst aged veterans, with >15,000 veterans hospitalized each year for stroke. However, even with early reperfusion treatment of ischemic stroke most aged patients experience significant residual deficits. A basic principle of stroke rehabilitation is that brain recovery requires co-activation of intent to use the extremity with motion. However, after stroke, both exercise and activity are limited by severe functional deficits. In this case combining brain and extremity electrical stimulation may substitute for intent to move. We propose that combining external brain stimulation and peripheral activation together with active behavior will enhance mouse stroke recovery through enhanced neural plasticity and brain blood flow, compared to either approach alone. If successful, these translational experiments will provide a novel approach to stroke rehabilitation through a clinically feasible protocol